Transcriptional Regulation of human natural killer cell function

Project Summary
Natural killer (NK) cells have the innate capacity to identify and eliminate virally infected cells. Human
cytomegalovirus (HCMV) infection increases the risk of severe health issues in newborns and patients with
immune deficiencies (such as AIDS patients or solid organ transplant recipients). Previous work in mice and
humans has demonstrated that NK cells are essential for host protection against herpesviruses such as HCMV,
and that mouse cytomegalovirus (MCMV) infection can be utilized to model and study HCMV infection in vivo.
While the transcriptional and epigenetic regulators associated with mouse NK cell activation and persistence
during viral infection have been well studied, they are still not well understood in human NK cells. Our long-term
goals seek to identify the relevant transcriptional regulators of human NK cell function following viral infection.
To address this, we performed a targeted CRISPR screen in primary PBMC-derived human NK cells
concentrated on transcription factors differentially expressed during human NK cell development. Of these
candidates, MEF2C was the sole transcription factor broadly required for human NK cell cytotoxicity,
proliferation, and antiviral cytokine production ex vivo. Analysis of PBMCs from patients with MEF2C
haploinsufficiency syndrome (MCHS) further demonstrated defects in NK cell proliferation and effector function
ex vivo, and Mef2c haploinsufficient mice displayed increased mortality during viral infection associated with
defective NK cell function. MEF2C was required to promote SREBP-dependent lipid import in response to
cytokine activation, and oleate supplementation restored intracellular lipid levels and the cytotoxicity of MCHS
patient NK cells. CRISPR-mediated knockout of individual SREBP isoforms in human NK cells revealed that
SREBP2, but not SREBP1, is required for NK cell effector functions. These results suggest that MCHS patients
with increased susceptibility to viral infections may be caused by an NK cell-intrinsic functional defect, and oleate
supplementation may represent an effective strategy to enhance immunity in these patients. While these
preliminary results implicate MEF2C as a critical regulator of human NK cells through regulation of the SREBP2
pathway, the precise mechanisms by which MEF2C is induced, and controls human NK cell functionality are
unknown. In Aim 1, we will determine the transcriptional and post-translational mechanisms of MEF2C regulation
in human NK cells. In Aim 2, we will determine the mechanism of action and in vivo therapeutic efficacy of oleate
supplementation on NK cell cytotoxicity. In Aim 3, we will investigate how the SREBP2 pathway promotes
antiviral cytokine production in human NK cells. In summary, the studies included in this proposal will contribute
to the fundamental understanding of how human NK cell effector functions are regulated by cell-intrinsic
metabolism, while also contributing to novel strategies to enhance the clinical use of NK cells during viral infection
and in immunocompromised patients.

Public health relevance
Project Narrative Human cytomegalovirus has been shown to cause serious health complications in immunosuppressed individuals and newborns. This proposal will define how a specific transcription factor, MEF2C, controls human natural killer (NK) cell metabolism and protective responses during viral infection. A detailed understanding of the molecular mechanisms that regulate human NK cells during viral infection may lead to novel immunotherapies and treatment strategies for immunocompromised patients.